Advancing Health Policy and Systems Approaches to Improved Delivery of Surgical Limb Salvage Procedures for Severe Chronic Wounds

PROJECT SUMMARY/ABSTRACT
In the United States, 2.4-4.5 million people suffer from chronic lower extremity wounds, costing the
health system up to $31.7 billion annually. A multidisciplinary approach is necessary for amputation reduction
in severe wounds, as nontraumatic amputation leads to a 5-year mortality rate of 50-75%. It has been
demonstrated that the establishment of limb salvage centers reduces amputation rates, improves provider to
provider education resulting in earlier referral, improves prevention measures and increases global functioning
of patients.
Currently, little is known about the state of limb salvage adoption by hospitals in the United States,
including which surgical modalities are most commonly used, their spread across regions and over time, and
the scale of operations relative to community-based need. Even less is known about how this care is organized
within local hospital markets and how the structure of these markets affects which patients receive limb
salvage versus amputations. This lack of fundamental knowledge stands as a barrier to improvements in the
organization and distribution of resource-intensive wound care teams to treat chronic wounds in the U.S. As a
result, limb salvage is characterized by fragmented delivery, inequitable provision, few quality standards, and
pervasive fee-for-service payment mechanisms with their well-known lack of incentives for quality or efficiency.
These issues are likely to grow in importance during the COVID-19 pandemic, as delays in care will likely lead
to more patients developing severe chronic wounds before seeking treatment.
This project will address these gaps by conducting the first large-scale assessment of limb salvage
spread, provision, and market effects for lower extremity wounds in the United States. Under Aim 1, will use
the 2005-2017 Healthcare Cost and Utilization Project (HCUP) – State Inpatient Database (SID) linked to the
American Hospital Annual (AHA) Survey to examine the role of hospital market structure, hospital factors, and
patient factors in the adoption and spread of limb salvage procedures and its effects on disparities in care.
Under Aim 2, we will engage an Expert Advisory Panel to help translate the findings from Aim 1 into a set of
actionable health system and policy strategies, disseminate findings to practitioners, and develop a research
agenda for advancing much-needed healthcare payment and delivery reforms in the provision of severe
chronic wound care. This study will advance AHRQ’s priority to spread evidence-based practices and develop
the foundation to address other priorities including comparative performance of systems and providers, and
development of performance-improvement incentives. These findings will be especially important to AHRQ
priority populations, including low-income, minority, rural, and people with chronic illnesses.

Public health relevance
PROJECT NARRATIVE Chronic lower extremity wounds can lead to amputations, which impose a significant burden on patients and society. While a multidisciplinary limb salvage approach has been established as the gold standard in reducing amputations, this approach is not widely or equitably used and there is a lack of understanding about how to best distribute limb salvage centers. The proposed study will use HCUP-SID data to examine the role of hospital market structure on the adoption of, and disparities in, use of limb salvage for chronic wounds and work with an expert panel to maximize the practice relevance of findings and develop a research agenda to advance health policy and systems approaches for improved delivery of surgical wound care.